Organizational strategies for improving evidence-uptake in intensive care

ABSTRACT
In recent decades multiple high-profile clinical trials have provided a rigorous evidence base for the
care of patients with acute respiratory failure requiring mechanical ventilation. Yet many patients still
do not receive these evidence-based treatments proven to save lives. The overarching goal of our
research program is to address this issue by defining the relationship between ICU organizational
behavior and evidence-uptake in critical care. Drawing off the rapidly evolving fields of organizational
psychology, decision science, and biomedical informatics, we will broadly investigate the ways in
which the interactive behaviors of the ICU team members can both facilitate and hinder efficient
translation of evidence into practice. We will pursue three integrated and complimentary lines of
research: (1) developing and refining novel strategies for measuring critical care performance; (2)
investigating the role of collective intelligence and transactive memory as key sociological mediators
of evidence-uptake in critical care; and (3) improving the value of novel decisional support tools such
as checklists and electronic prompting for the use of evidence-based practice. To perform this
research we will leverage existing collaborations with state and regional health systems as well as the
expertise of the principal investigator, a physician-scientist with over 15 years’ experience studying
the link between ICU organization and outcome for patients with critical illness. Together, our results
will provide hospitals and clinicians with innovative tools for improving critical care performance on a
national scale, directly leading improved outcomes for patients with acute respiratory failure and other
forms of critical illness.

Public health relevance
PUBLIC HEALTH RELEVANCE Over 700,000 Americans receive invasive mechanical ventilation in an ICU each year. Many of these patients do not receive evidence-based therapies proven to save lives, leading to preventable morbidity and mortality. Innovative strategies to overcome the barriers to evidence-based practice and speed knowledge translation in the ICU are urgently needed. By developing novel approaches for knowledge translation in acute respiratory failure, this research program will help new treatments reach the bedside more quickly, leading to improved outcomes for critically ill patients.